Common Themes in Reproductive Diversity

Project Summary
This proposal requests a third renewal of a highly successful T32 Institutional National Research Service Award
to Indiana University, entitled “Common Themes in Reproductive Diversity” (CTRD). The award will support
broadly integrative training in the areas of sexual reproduction and development. Training will focus on behavior
in both humans and other animals and will address key questions in three related themes: (1) Developmental
contributions to reproductive behavior, (2) Origins and expression of differences among the sexes, and (3)
Interactions between sex, health, and disease. Indiana University's excellent support for research and its globally
recognized strengths in animal behavior, endocrinology, human sexual health, and evolution of development will
ensure high quality training. The 21 Training Faculty and 6 Affiliated Resource Faculty are drawn from 3 schools
(Medical, Public Health, College of Arts and Sciences, including Ph.D. granting departments in the College (e.g.,
Anthropology, Biology, Gender Studies, Psychological and Brain Sciences) and 3 additional degree-granting
programs (Medical Sciences, Neuroscience, and Cognitive Science). They are also associated with 1 or more
of 5 research centers, most importantly the Center for the Integrative Study of Animal Behavior (CISAB), the
Kinsey Institute for Research on Sex, Gender and Reproduction, and the Center for Genomics and
Bioinformatics. Support is requested for five years to enable training of 4 predoctoral and 2 postdoctoral students
each year to be drawn from a deep pool of talented applicants. In addition to course work in the fundamentals
and intensive research training, trainees will participate in (1) a research-based course focused on Concepts in
Reproductive Diversity, (2) an interdisciplinary, hands-on methods course, Techniques in Reproductive Diversity,
a 3) a Research Ethics course, and 4) a Professional development course all co-taught by the training faculty
and enhanced by invited distinguished visiting scientists. Active participation in a monthly breakfast research
forum and other opportunities will allow trainees to accomplish important professional training including creating
individual development plans (IDPs), preparing for more than one career outcome, and enhancing the
reproducibility and transparency of their research. Trainees will also organize and present research at a highly
successful and broadly attended CISAB conference. Predoctoral trainees will be drawn from the most highly
qualified applicants to the degree-granting programs of the Training Faculty. Postdoctoral trainees will be
recruited nationally, will be chosen based on their accomplishments and the potential for CTRD training to
broaden their skills and perspectives, and will be expected to foster research collaboration among CTRD trainees
and laboratories. Intense effort will be made to enhance recruitment and retention of diverse trainees, to provide
mentoring opportunities through a highly effective undergraduate program for underrepresented minorities, and
to recruit and support individuals with disabilities or from disadvantaged backgrounds.

Public health relevance
Project Narrative Understanding the sexual phenotype –or gender -has far reaching implications for human health and well-being. Trainee research on steroid hormones, maternal stress, changing environments, maternal and infant health, and healthy sexual behavior and reproduction, using human, non- human model systems, and evolutionarily diverse non-model systems will lead to insights into the basic mechanisms of reproduction and development and to understanding of the physiological differences between the sexes and their influence on illness and health outcomes, all of which will be valuable to policy makers, medical research, and health care.